Picornavirus Genome Replication

All positive-strand RNA viruses require host membranes for multiplication, even non-enveloped viruses like
poliovirus (PV). In some cases, viruses simply hijack host membranes and use them intact. However, in
other cases, viruses remodel the entire host lipidome to create virus-induced membranes with unique
phospholipid composition, which, in turn, confers upon these membranes unique biochemical and
biophysical properties to enable unique biological function. PV, related enteroviruses, and likely many
other viruses, fall into this latter category. What is so astonishing about the PV-induced transformations is
that they only require translation of the infecting RNA, without the need for genome replication or host
transcription. What this circumstance suggests is that post-transcriptional and/or post-translational
mechanisms exist in the mammalian cell cytoplasm capable of completely reprogramming phospholipid
biosynthesis and membrane biogenesis in a matter of minutes and that one or a few master regulators,
which can be coopted by PV, likely control these mechanisms. The overarching premise of the research
proposed during the extension is that our studies will illuminate mechanisms regulating membrane
biogenesis, function, and trafficking by understanding how PV hijacks and coopts these mechanisms. We
will pursue the following specific aims: Aim 1 - Study contributions of 3CD to virion assembly, trafficking,
and egress; Aim 2 – Coopting of c-Fos by PV to induce phospholipid biosynthesis and membrane
biogenesis; and Aim 3 – Characterization of the dynamics, mechanisms, and functions of host-lipidome
remodeling during PV infection.

Public health relevance
RELEVANCE (See instructions): Picornaviruses represent an existing and emerging threat to U.S. public health. Achievement of the goals of the application will provide novel targets and mechanisms for development of inhibitors to treat infections by picornaviruses, especially those for which vaccines are not available.